IND FOR RETROVIR BRAND ZIDOVUDINE FOR CHILDREN WITH HIV DISEASE

The purposes of this treatment IND program are to facilitate the use of Retrovir in children who are HIV infected and either symptomatic or have fewer than 400 CD4+ lymphocytes and for whom no satisfactory alternative treatment is available; to provide free Retrovir to these children on a temporary basis; and to monitor adverse events attributable to Retrovir.